ENDOGENOUS ADENOSINE AS AN ENDOGENOUS SYMPATHETIC MODULATOR

Determine if interstitial levels of adenosine are increased by ischemic excerise in humans, to test the hypothesis that endogenous adenosine contrubites to the sensory stimulation and reflex sympathetic activation evoked by ischemic excerise in humans and that edogenous adenosine acts as a local endogenous sympathetic modulator by blocking norepinephrine release in the forearm.